The role of type 2 inflammation in the initiation and progression of metaplastic differentiation and neoplastic transformation of gastric epithelia

Chronic inflammatory damage in the stomach can lead to metaplastic differentiation of epithelial lineages
and eventual development of gastric (stomach) cancer (GC). Gastric adenocarcinoma (GA) accounts for most
GC cases. The etiology of GA has been described as a histopathological progression from atrophic gastritis,
metaplasia, dysplasia to adenocarcinoma. Gastric metaplasia includes Spasmolytic Polypeptide-Expressing
Metaplasia (SPEM), which is associated with human GA as a pre-neoplasia. Extensive studies have established
H. pylori as a major environmental risk factor for GC and ~1% of infected cases are linked to GC. The role of
host factors for GC are also indicated by accumulating evidence. As in other diseases, rare cases of genetic
mutations can offer novel insights that may be broadly relevant. Indeed, gastritis and GC development in
recently-identified rare cases of human CTLA4 haplo-insufficiency highlight the potential of chronic inflammation
in GC. A recent survey of 133 patients with CTLA4 haplo-insufficiency from ~2-50 years of age found atrophic
gastritis in 9% of the patients and GC in 3% of the patients. The finding from these rare cases also consists with
evidence for an association of human GA with a genetic predisposed CTLA4 insufficiency due to gene
polymorphisms. We recently reported a transgenic CTLA4 RNAi “knockdown” (CTLA4KD) model for GC initiated
by CTLA4 insufficiency. On susceptible genetic backgrounds, CTLA4KD mice exhibited spontaneous
development of SPEM with 100% penetrance, even in germ-free conditions. Corroborating the genetic evidence,
CTLA4 blockade with monoclonal antibodies (mAb) also induced SPEM in mice. With age, SPEM progressed
to GA in all CTLA4KD mice. Thus, CTLA4KD mice not only model human GC initiated by CTLA4 insufficiency,
but also capture a shared feature of SPEM and GA progression with an entire cascade from gastritis, metaplasia
to invasive adenocarcinoma. Furthermore, the CTLA4KD model illustrated a critical role of autoimmunity in GC.
Autoimmunity has been suggested to be the cause of the recently identified rise of noncardia GC in Americans
who are less than 50 year old, especially non-Hispanic white women. Overall, our preliminary data suggest that
the causality of CTLA4 insufficiency in GC was due to a type of inflammatory “crosstalk” between immune and
epithelial cells. We hypothesize that type 2 inflammation initiates metaplastic differentiation of gastric epithelia
and drives malignant transformation of the pre-neoplastic lineage into invasive adenocarcinoma. Specifically, we
will: 1) determine the subtypes of immune cells that cause aberrant epithelial-immune interaction in mucosae
leading to metaplastic differentiation and malignant transformation; 2) examine the origin and fate of pre-
neoplastic cell differentiation mediated by epithelial-intrinsic signaling of type 2 cytokine receptors; 3) identify the
growth factors in type 2 inflammatory niches that propel the proliferation and transformation of epithelial lineages
in the stomach. The study will reveal the origin and fate of pre-malignant cells, and help a long-term goal to
identify potential biomarkers and targets to break the link between inflammation and tumorigenesis.

Public health relevance
This study investigates how chronic stimulation by cytokines leads to inflammation and cancer in the stomach. The knowledge generated from this study will help design strategies to break the link between inflammation and cancer development as well as to block pro-tumor inflammatory signal while preserving the anti-tumor effectors for cancer prevention and treatment.